Gamma-Secretase: Structure of an Intramembrane Protease

Project Summary/Abstract Not applicable (Change of Grantee Organization Transfer Application).

Public health relevance
Project Narrative Not applicable (Change of Grantee Organization Transfer Application).